IL 12 GENE THERAPY USING INJECTION OF TUMORS W/GENETICALLY ENGINEERED FIBROBLAST

The objective of this phase I, II study is to define the local and systemic toxicity and immunmodulatory effects associated with peritumoral injections of fibroblasts genetically engineered to secrete IL-12 and evaluate the clinical efficacy of this procedure. A total of 18 patients with cutaneous cancer lesions of 4 types of cancer (melanoma, breast cancer, head and neck cancer and cutaneous T-cell lymphoma) will be enrolled in the preliminary study of this maximum tolerable or "possible" dosage study.